ConProject-002

Project Summary/Abstract Project SEAMIST, a WTP awardee with primary responsibility for the training of workers in the maritime industries and community for hazardous chemical safety and response, proposes to provide this essential worker community with critical training in awareness and safe working habits in response to the current COVID19 outbreak. Project SEAMIST will deliver, via established, facilitated online procedures, COVID19 training, as developed and provided by the NIEHS WTP, with local optimization and adaptation for our maritime clientele. Project SEAMIST has identified a marketing agent, Resolve Maritime Academy, and client industries including ship and port workers, warehouse employees and freight forwarders, who have expressed a need for such training. In addition, Project SEAMIST has identified an expert collaborator, Dr. Alex Isakov, previously leader of a WTP infectious diseases program, to act as a subject matter expert and facilitator in the delivery of this training. Dr. Isakov's program was largely performed online, and while Nova Southeastern University has extensive experience delivering online learning, we welcome Dr. Isakov's input into trainings in this critical subject.

Public health relevance
PUBLIC HEALTH RELEVANCE: Project SEAMIST is a long-standing NIEHS-funded WTP specializing in delivering face-to-face chemicals hazards awareness and response training for the maritime community. In the face of the current COVID19 crisis (NIEHS – COVID-19, 2020, March 26,) Project SEAMIST has committed to delivering awareness and safety training on this topic specifically developed for the worker community and provided by NIEHS, after optimization for our target worker population. We have familiarized ourselves with the material, staff and trainers have attended “train-the-trainer” sessions, and we have established our expertise in online training in recent months, and are now prepared to deliver online training based on the provided NIEHS training tool, to our maritime worker community.